Cell-type and sex-specific organization and neurexin-3 utilization at parvalbumin inhibitory synapses in ventral subiculum

Project Summary
The ventral subiculum (vSUB) is the major output structure of the ventral hippocampus and plays an integral role
in the regulation of stress, fear and reward processing. Hyperactivity of vSUB is a pathophysiology common to
schizophrenia and addiction disorders and is proposed to arise from reduced local inhibition onto vSUB principle
neurons, identified as burst and regular spiking neurons, which engage in parallel information processing circuits.
There is evidence from human patients and mouse models that inhibitory parvalbumin basket cells (PVs) in
vSUB are specifically disrupted in schizophrenia. PVs are a prominent class of interneurons that provide potent
inhibition of principle neurons. Despite the obvious importance of vSUB PVs to normal function and their
relevance to disease, very little is known about the fundamental connectivity, properties of synaptic transmission,
or molecules that govern synapses made by PV interneurons onto regular and burst spiking principle neurons of
vSUB. Additionally, although sex differences in schizophrenia, addiction, and stress have been described for
decades, little is known about underlying sex differences within brain regions associated with these diseases,
such as vSUB. Neurexin-3 (Nrxn3), an evolutionarily conserved and essential presynaptic adhesion molecule,
may exert dominant and potentially distinct control of PV synaptic properties in vSUB. Neurexins are critical for
synapse specification and synaptic transmission, and Nrxn3 exhibits diverse brain region, cell type, and synapse
specific functions. Notably, mutations in Nrxn3 have been repeatedly linked to schizophrenia and addiction and
Nrxn3 is robustly and uniquely expressed in hippocampal PVs, indicating it plays a critical role at vSUB PV
synapses and may contribute to the etiologies that underlie these disorders. The specific function(s) of Nrxn3 at
PV synapses, however, has surprisingly never been described.
Supported by strong preliminary data, here, I will provide a comprehensive interrogation of the cell-type- and
sex-specific wiring, synaptic transmission and usage of Nrxn3 by PVs among regular and burst spiking cells in
vSUB. I will employ a multi-disciplinary approach consisting of mouse genetics, viral injections, optogenetics,
and molecular replacement together with electrophysiology in acute vSUB slices to assess 1) the specific
function(s) of Nrxn3 at PV-regular spiking and PV-burst spiking cell synapses of male and female mice and 2)
the specific Nrxn3 isoforms and domains required to regulate these functions. This project will expand our
understanding of the functional organization and molecular constituents that shape inhibition within a brain region
associated with schizophrenia, addiction, and stress disorders.

Public health relevance
Project Narrative Normal brain function relies on precise communication between inhibitory cells and excitatory cells at their synaptic contacts and disruption to inhibitory synaptic function is often observed in neuropsychiatric disorders. Here we will investigate how inhibitory signaling is established in a sex-dependent manner in a brain region that is commonly linked to schizophrenia, stress and addiction disorders, and identify how neurexin-3, a gene shared among all vertebrate animals, participates to control inhibitory synaptic properties.